WHOLE BODY MEASUREMENTS OF BONE AND SOFT TISSUE BY DEXA

This protocol was undertaken at the request of the National Center for Health Statistics in collaboration with the University of California San Francisco. The intent of this study is to compare the results of body composition measurements with these two instruments. All studies have been completed and the analysis is underway.